A System to Support Development and Success of NCI-Sponsored Trials for Rare Diseases

R50 Abstract – Reiss
Gastrointestinal maligancies remain lethal and difficult-to-treat, with poor outcomes for
many patients. In spite of this, we are in a moment of a scientific and clinical revolution
with the development of biomarker-driven therapies for selected patients. With these
advances come multiple new questions for the field, many of which the NCTN
infrastructure is optimally suited to address. To date, I have demonstrated a strong
commitment to clinical and translational research for populations of patients with rare
subsets or biomarkers, including via the development and implementation of NCI-trials
at my own institution: I am the international study chair and lead accruer for EA2192 as
well as the study champion and lead national accruer for SWOG-2001. On the larger
scale, I hold leadership roles within the Abramson Cancer Center (ACC) at the
University of Pennsylvania and at the NCTN. I serve as the co-chair of the ECOG-
ACRIN GI Committee, I am the co-leader of the ACC Cancer Therapeutics Program and
I am the co-leader of the ACC Pancreatic Clinical Trial Program. These leadership
positions are optimal platforms upon which to spearhead programs that (1) formally and
longitudinally assist junior and mid-career oncology faculty in their quests to develop
investigator-initiated studies and (2) develop a program at the NCTN that focuses on
developing realistic trials for rare populations and then on accruing them successfully.
To date, I have demonstrated a persistent and strong commitment to the NCI research
enterprise. I have been involved with NCI-related research since my early career,
initially attending meetings and later developing my own protocol, EA2192. Based on
my steady engagement and input, I was appointed as the co-chair of the GI Committee
in 2022 alongside Jordan Berlin (see LOS). Together, we have made a commitment to
improving the process of clinical trial development, a mission that will be critical in order
for the NCTN to remain competitive in an ever-changing landscape. Over the past three
years, we have employed multiple initiatives including boosting the education of our
investigators about the NCTN process, leaning on the excellent Working groups chairs
to fine-tune concepts prior to Committee Presentation and providing substantial
assistance during the submission process. With the support of the R50 Research
Specialist award, I will build further on this approach in two ways: At the ACC, I will
develop a sustainable program for early and mid-career investigators to provide
longitudinal support in the development of investigator-initiated trials, with a particular
focus on rare disease studies that can be best executed via the ECOG-ACRIN system.
Within the NCTN, I will employ a novel program assisting investigators in the
development and successful enrollment of trials for rare disease populations, a subset
of studies that have lost ground since the COVID pandemic. Specifically, I will create a
living resource for NCTN investigators that focuses on methods to design practical,
feasible studies and will provide longitudinal support to those across the NCTN who are
developing studies in this space. My ultimate goal is to develop and implement
pragmatic clinical trials that address key questions in the field of gastrointestinal
malignancies, particularly for patients with rare subsets of disease.

Public health relevance
Project Narrative Clinical trials for patients with rare genomic or histopathologic subtypes of cancer are critical for the progression of the field. Such studies contribute to the fundamental knowledge about cancer biology as well as improving the outcome for afflicted persons.